Understanding and Designing pH-Responsive Peptides in Confined Nanoscale Environments

Project Summary:
The confinement, localization, and nanoscale organization of biomolecules can dramatically alter their
biochemical and physiological properties creating opportunities for in vivo sensing and enhancing
their use as therapeutics. While these principles are relatively well-studied for oligonucleotides, which
are frequently used as vaccines, antisense therapeutics, and theranostics, they are less well-studied
for short biological peptides of similar lengths (10-100s of amino acids). One particularly relevant
class of peptides are intrinsically disordered proteins (IDPs), which are highly reconfigurable in
response to environmental stimuli, including temperature, pH, ionic strength, and mechanical force.
While fundamental studies have revealed some of these effects on solution peptides, understanding
these properties for IDPs that are confined or organized at the nanoscale is less well understood.
This represents a significant knowledge gap because understanding and controlling the dynamic
properties of IDPs at the nanoscale could enable the creation of stimuli-responsive in vivo pH sensors
while providing insights into the impact of confinement on clinically relevant IDPs regions. The long-
term goal of our work is to develop a comprehensive and forward-looking framework for
understanding, and ultimately designing, the biophysical properties of IDP-nanoparticle architecture.
The objective of this project is to reveal the sequence-, density-, and stimuli-dependence of IDPs
bound to small (~10 nm) spherical nanoparticles, and its ability to influence and control the physical
properties of nanoparticle core. The central hypothesis of this work, based upon previous work on
DNA-nanoparticle conjugates (Ross) and IDP pH sensitivity (Gage), is that localization and
confinement of IDPs onto nanoparticle constructs will influence their structural plasticity to pH,
temperature, and ionic strength. Consequently, IDP-nanoparticle conjugates can generated with
tunable responsivity to their environment, leveraging the biophysical properties of the IDPs and the
physical properties of the inorganic nanoparticle core. The approach for testing our central hypothesis
comprises two specific aims: 1) Reveal the distinct biophysical properties of nanoparticle-bound IDPs
compared to free-in-solution IDPs; and 2) Determine how IDP sequence and density influences
nanoscale optical readouts for sensing ionic strength, temperature, and pH changes. This study is
innovative as it represents one of the first approaches to coupling IDPs to nanoparticles and the
insights gained from this study are necessary to develop a system that is tunable for specific
environmental changes. These studies are a critical first step towards developing new IDP-
nanoparticle sensors that will have a range of biomedical applications.

Public health relevance
Project Narrative: The proposed research is relevant to public health because there are a number of glutamate rich Intrinsically Disordered Regions (IDR), especially in the proteins that form the contractile machinery of muscle. The focus of the proposed work is to develop an understanding of the chemical and biological nature of nanoparticles with IDPs attached and what environmental signatures lead to changes in those properties. As a result, this work is relevant to the part of NIH’s mission pertaining to developing knowledge of basic biological mechanisms, which will facilitate the development of novel sensors that will have both potential therapeutic and research applications.